Developmental Research Program

DEVELOPMENTAL RESEARCH PROGRAM (DRP): SUMMARY
The main goal of the Developmental Research Program (DRP) of the Yale SPORE in Lung Cancer (YSILC) is
to identify and fund innovative pilot projects that possess translational potential for making an impact in the field
of lung cancer in the areas of risk assessment; early detection; biomarkers for prognosis, therapy, and prediction;
novel targets of tumor biology; and novel therapeutic approaches. Investigators of funded DRP projects are
strongly encouraged to collaborate with other investigators within and outside of Yale, including other SPORE
research communities, with the goal that these projects will evolve into independent full YSILC projects or
equivalent scale studies. The objective of the YSILC DRP is to develop innovative lung cancer translational
research. Projects making significant progress will be considered for incorporation into a full project if there is a
programmatic need and upon agreement of the YSILC leadership in consultation with the Internal Advisory
Board, External Advisory Board, and NCI staff.